Defining Mechanisms of MLKL-Mediated Mitochondrial Damage in Necroptosis and Mycobacterium tuberculosis Infection

PROJECT SUMMARY
Mitochondria are essential regulators of cell death and innate immune responses, and their dysfunction is a
hallmark of many infectious and inflammatory diseases. Although mitochondria are known to influence various
forms of programmed cell death, their involvement in necroptosis—a lytic form of programmed cell death
mediated by the pore-forming protein MLKL—remains poorly understood. My preliminary data indicate that
inhibition of Drp1, a key regulator of mitochondrial fission, enhances necroptosis and promotes the recruitment
of active MLKL to mitochondria, accompanied by loss of mitochondrial membrane potential, suggesting that
Drp1-mediated mitochondrial fission acts as a protective mechanism that limits MLKL-induced mitochondrial
damage. This key finding motivates my overarching hypothesis that mitochondrial membrane dynamics
modulate cellular sensitivity to necroptosis by influencing the affinity of mitochondria for MLKL. Consequently,
the overall objective of this proposal is to define the mechanism and inducing conditions by which MLKL-
mediated mitochondrial damage enhances inflammatory cell death. Aim 1 will define the impact of MLKL
recruitment on mitochondrial integrity and necroptotic signaling, thereby elucidating how mitochondrial damage
amplifies necroptosis. Aim 2 will focus on identifying conditions that promote MLKL translocation to mitochondria
during necroptosis, investigating factors such as impaired mitophagy, cardiolipin externalization, and
mitochondrial network hyperfusion. Additionally, as Mycobacterium tuberculosis (Mtb) infection of macrophages
in vitro is known to both alter mitochondrial dynamics and act as an inducing condition for necroptosis, I will
evaluate the contribution of MLKL-mediated mitochondrial damage to cell death during Mtb infection. By defining
the molecular mechanismsthat drive inflammation through MLKL-mediated mitochondrial damage, this research
will enhance our understanding of the interplay between mitochondrial dynamics and inflammation, potentially
facilitating the rational development of therapeutic interventions aimed at modulating these processes in various
inflammatory and infectious diseases.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction is a major contributor to human disease. This project aims to study the relationship between mitochondrial dynamics and inflammation by defining the role of mitochondrial damage in necroptosis, a lytic and highly inflammatory form of programmed cell death. The findings will enhance our understanding of how mitochondria influence innate immunity and potentially inform the development of novel therapeutic strategies that target mitochondrial function to control inflammatory cell death.